TILUDRONATE ON BONE MASS IN POSTMENOPAUSAL WOMEN

This is a phase III, double-blind, placebo-controlled, multi-centered, dose-ranging, efficacy and safety study of tiludronate in post-menopausal women with one or more vertebral fractures. The study will include a minimum of 300 subjects randomized to either placebo, 50 mg or 200 mg tiludronate orally once daily for the first seven days of each month of the two year treatment phase. Daily supplemental calcium will be used for the remainder of each month. Upon completion of the treatment phase, a one year observation phase will consist of daily calcium supplement for all subjects.